Administrative Core

PROJECT SUMMARY
ADMINISTRATIVE CORE
The Administrative Core will be responsible for coordinating the scientific and financial activities of the PPG. It
will establish policies for use of the Cores and coordinate communication between the Projects and other Cores,
as well as with Advisory Committees. This Core will be responsible for scheduling and arranging monthly
meetings of PPG participants and preparing period scientific and financial reports of progress. Maintenance and
monitoring of institutional authorizations for animal use and other laboratory regulations will be performed
through the Administrative Core.